STUDIES OF THE STRUCTURES OF FCY RECEPTORS

The aims of this grant proposal are: (1) To further characterize the structurally unique FcGamma receptors isolated from human monocytes, B lymphocytes, and non-B lymphocytes. Purified cell populations will be labeled with radioactive isotypes, and radiolabeled FcGamma receptors will be isolated by repetitive chromatography. Labeled FcGamma receptors will be analyzed by SDS-polyacrylamide gel electrophoresis. Tryptic peptide maps and amino acid sequences of the unique receptors and their fragments will be examined for homology. (2) To isolate and characterize the FcGamma receptors of other human leukocyte populations e.g. eosinophils, human cell lines, leukemia cells using similar procedures. (3) To prepare monoclonal antibodies against each of the distinct human FcGamma receptors.F(ab) and F(ab)'s fragments of monoclonal proteins will be carefully characterized to rigorously document anti-receptor activity. (4) To study interactions between the distinct human FcGamma receptors and immunoglobulins which differ by subclass, class, species of origin, or state of aggregation. (5) To determine whether human FcGamma receptors have multiple components. Biosynthetically radiolabeled receptors and chemically crosslinked receptors will be examined for evidence of, and properties of, possible associated molecules. (6) If FcGamma receptors are phosphoproteins, to examine whether receptors are selectively phosphorylated (or dephosphorylated) during non-specific or immunologic cell activation. (Disciplines involved are immunology, protein chemistry, and cell biology.) These aims will further our long term objectives: (a) Learning about the distributions, structures, and functions of the structurally unique human FcGamma receptors, their interactions with immunoglobulins, and their mechanisms of action. (b) Determining whether FcGamma receptors may be involved in complications of leukemia and whether detection of unique FcGamma receptors may be useful in lymphoma classification and treatment. (c) Understanding mechanisms of immunodeficiency and other immunologic diseases.